Integrating population genomics and microbial metagenomics of the lone star tick, an expanding arthropod disease vector

Integrating population genomics and microbial metagenomics of the lone star tick, an expanding
arthropod disease vector
PROJECT SUMMARY/ABSTRACT
Ticks are the most important vectors of disease-causing pathogens in the United States. The lone star tick,
Amblyomma americanum, is a competent vector of various pathogenic microorganisms. There are several
critical knowledge gaps in our understanding of the basic biology of the lone star tick, an arthropod disease
vector that is rapidly expanding its geographic distribution into the Midwest and Northeast. Little is known about
how the diversity of the tick’s genome and the microbial diversity of the tick’s microbiome affect the ability of
specific pathogens to infect a tick. The main objective of this research is to generate an integrated genetic
epidemiology for tick-borne diseases that incorporates the genomic diversity of vector, the species diversity of
its microbiome, and the prevalence of known pathogens. The overarching hypothesis is that genomic diversity
of tick vectors is positively associated with microbial species diversity and negatively associated with pathogen
prevalence. The Principal Investigator will use next-generation DNA sequencing to test the overarching
hypothesis and achieve the main objective of this project through three specific aims: (1) Investigate the spatial
distribution of genomic variation among populations of lone star tick near the western and northern species range
boundaries. The working hypothesis is that a cline of genomic diversity corresponds to increasingly stressful
climatic conditions at the edges of the species range, suggesting that range expansion coincides with
microevolutionary change. (2) Characterize the microbiome of lone star tick and assess its relationship to host
genomic diversity. The working hypothesis is that greater genomic diversity of ticks permits a greater microbial
species diversity in ticks, suggesting that host genotype affects microbiome composition. (3) Examine the effects
of genomic diversity and microbial diversity on pathogen infection in individual ticks. The working hypothesis is
that high genomic and microbial diversity of individual ticks reduces infection by pathogenic bacteria, suggesting
that competitive interactions of microbes inside of ticks govern the prevalence of specific tick-borne pathogens
at broader scales. This study is innovative because it will (a) uniquely bridge methodologies in population
genomics, bacterial metagenomics, and community ecology of vector-borne pathogens; (b) generate genomic
data that will be a valuable resource for future investigations of A. americanum and other ticks; and (c) illuminate
the importance of accounting for genomic and microbiome diversity in laboratory-reared ticks used in studies of
pathogen transmission, host immunology, and acaricides. This study is significant because it will shed light
on the microbial interactions within individual ticks that may influence pathogen dynamics. Discovering bacterial
lineages or assemblages that competitively inhibit infection by pathogens within ticks will be a significant step in
controlling diseases vectored by ticks and other arthropods. Furthermore, this proposed study will enhance the
infrastructure for research at Pepperdine University and will provide crucial opportunities to undergraduate
students interested in careers in biomedical sciences and vector biology.

Public health relevance
PROJECT NARRATIVE Ticks cause more than 40,000 cases of tick-borne diseases every year in the United States. However, it is not well understood why some ticks are infected with pathogens and others not, or why tick-borne diseases are more prevalent in some regions than in others. This research will employ an integrated approach to investigate possible links between the diversity of a tick’s genome, the microbial diversity of a tick’s microbiome, and the ability of specific pathogens to infect a tick.